Changes in monocyte small noncoding RNAs as a predictor of cognitive decline in mild cognitive impairment and Alzheimer's disease

ABSTRACT
Twenty years after 9/11, the World Trade Center (WTC) responders show elevated rates mild cognitive
impairment (MCI), an early sign of Alzheimer’s disease (AD) or AD-related dementia (ADRD). MCI is often
regarded as an intermediate stage between normal aging and dementia; thus it provides a window of opportunity
to understand the pathogenesis of the disorder and identify factors that lead to the conversion of MCI to
dementia. Epigenetic vulnerability and gene-environment interactions have been implicated in the etiology of
ADRD. In particular, small noncoding RNAs (sncRNAs) have been shown to be promising biomarkers and
provide insights into its pathophysiology. Preliminary findings further revealed that monocyte subpopulation
showed the largest changes in transcriptome associated with MCI; in line with evidence that monocytes play a
pivotal role in mediating the interface between central and peripheral systems via transduction through the blood
brain barrier. Despite this, there is no study which has investigated the epigenetic regulation by sncRNAs in
monocyte subpopulation that may explain how these changes affect downstream gene expression and proteins
associated with AD neuropathy and disease progression. This proposal builds on the preliminary findings in
monocyte transcriptome and capitalizes on existing biobank and clinical data by evaluating monocyte sncRNA
via smRNA-seq in a subset of 100 responders over a 24-month period. The proposed study will determine if
changes in monocyte sncRNAs are associated with changes in clinical phenotype; and identify the gene targets
of sncRNAs in monocyte subpopulation associated with cerebral neuropathology. To enhance the impact of this
study, an exploratory aim is included to identify a multi-omic signature by integrating monocyte sncRNAs, mRNAs
and plasma proteins that predicts changes in clinical phenotype. This study would be the first to examine the
synergy between monocyte sncRNAs, mRNAs and plasma proteins in individuals converting to dementia.
Findings from this study will shed light on regulation of monocyte responses in disease progression, help identify
novel blood-based biomarkers that may inform treatment efforts.

Public health relevance
PROJECT NARRATIVE World Trade Center (WTC) responders show elevated rates of mild cognitive impairment (MCI), an early sign of AD or a related dementia (ADRD). This study will examine small non-coding RNAs in monocyte subpopulation of Stony Brook WTC Health Program responders within a longitudinal study design, and integrate them with monocyte transcriptomic data to identify molecular mechanisms underlying monocyte dynamics and the biological processes involved in the progression of MCI to dementia. This knowledge will help researchers identify novel blood-based biomarkers for early detection of Alzheimer’s disease, and inform development of novel treatments.